Imaging & Spectroscopy Core

Project Summary – Imaging and Spectroscopy Core
Imaging is a major driver of discovery and translation in biology and medicine. The use of imaging and
spectroscopic approaches can often provide insights that may not be available with other techniques that require
sample processing. While an Imaging and Spectroscopy Core does not formally exist at the University of
Arkansas, the key ingredients necessary to establish one are already present on campus. A range of optical
microscopy and spectroscopy instruments are already available for use by other investigators, with several of
these set up as service centers. These existing resources will be consolidated and expanded to establish an
Imaging and Spectroscopy Core that will meet the research needs of the proposed Arkansas Integrative
Metabolic Research Center (AIMRC), have long-term benefits for researchers at the University of Arkansas, and
other campuses in the state and in this region of the U.S. The range of technologies available within the Core
will allow project leaders to shed new light on cell and tissue metabolism, thus enabling novel discoveries as well
as clinical translation of such discoveries. Close interaction between the Imaging and Spectroscopy Core and
COBRE project leaders as well as the Data Science and Bioenergetics Cores will lead to new innovations in
research methods that will benefit future COBRE investigators as well as the broader campus research
community. Hands-on training in imaging technologies will be provided to Center members, the campus and
biomedical researchers in Arkansas. The long-term goal of the Imaging Core is to develop and integrate
advanced imaging approaches needed by AIMRC members and become fully independent of COBRE support
by the end of Phase Ill. The short-term goal for COBRE Phase I is to provide state-of-the-art imaging techniques
that can be incorporated into Center projects, develop new image analysis approaches in collaboration with
project leaders and the Data Science Core that will support the long-term goal and provide support/educational
opportunities to Center members. The specific aims of this proposal are to 1) Establish a state-of-the-art imaging
and spectroscopy core at the University Arkansas that meets the needs of the COBRE project leaders and
accelerates their progression to independence; 2) Identify and develop new applications of optical microscopy
and spectroscopy on campus that synergize with the Bioenergetics and Data Science Cores and lay the
foundation for long-term sustainability of the Center; and 3) Provide consultation and coordination, technical
assistance and educational opportunities in support of experimental design, sample preparation, data acquisition
and analysis, and preparation of high-quality figures for publications and grant applications related to imaging.